Mechanism of a hypothiocyanous acid reductase

PROJECT SUMMARY/ABSTRACT
The innate immune system deploys a suite of oxidants to combat infection by bacterial pathogens and control
the human microbiome. Among these are hypothiocyanous acid (HOSCN), a potent thiol-specific oxidant
capable of killing many bacteria. Unlike other immune-derived oxidants, HOSCN is non-toxic to human cells and
is constantly produced in saliva, tears and epithelial fluids lining the respiratory tract as a defense against
bacterial colonization. We recently discovered that many human-colonizing bacteria express a flavin-dependent
HOSCN reductase (Har) that rapidly neutralizes HOSCN upon reduction with NAD(P)H, providing resistance
against HOSCN toxicity. Har is a member of the flavoprotein disulfide reductase (FDR) family, albeit with an
unusual function, as these enzymes typically catalyze the reversible reduction of disulfide-containing substrates.
Har is also found in major human pathogens like Staphylococcus aureus, Streptococcus pneumoniae and
Escherichia coli O157:H7, for which antibiotic resistance is a growing threat, and deletion of the har gene
dramatically attenuates S. pneumoniae colonization in mouse models, establishing Har as an important virulence
factor. This project aims to elucidate the chemical and catalytic mechanisms of Har. The first aim involves
mutagenesis and stopped-flow kinetics to identify reaction intermediates and determine the role of Har-specific
active site residues in the mechanism of HOSCN reduction by Har. The second aim utilizes transient kinetics
and measurement of kinetic isotope effects to define the sequence of events that occur during Har’s reaction
with NAD(P)H. The third aim seeks to understand the mechanism behind Har’s ability to use both NADPH and
NADH as a reductant, which is highly unusual among FDR family enzymes. Protein engineering will be used to
generate Har variants with altered NADPH/NADH specificity, and these will be used to test the hypothesis that
Har’s lax pyridine nucleotide specificity is critical for its ability to provide resistance against HOSCN. Together,
these research activities will generate fundamental insights into a widespread bacterial defense mechanism
against the innate immune system, paving the way for developing inhibitors targeting Har function. Additionally,
this project will enrich the research environment at a regional undergraduate institution, exposing undergraduate
students to meritorious research involving enzymology and transient kinetics.

Public health relevance
PROJECT NARRATIVE The innate immune system constantly produces hypothiocyanous acid as a defense against bacterial infection. Several bacterial pathogens contain a hypothiocyanous acid reductase (Har) that neutralizes this component of the immune system, allowing them to cause disease. This research project will provide fundamental insight into Har’s mechanism of action, which should aid the development of antimicrobial agents targeting Har function.